Ethno-epidemiology of HCV, HIV and Overdose associated with Drug Markets and Drug Tourism

This Diversity Supplement will be conducted based on data obtained from the study Ethno-
epidemiology of HCV, HIV and Overdose associated with Drug Markets and Drug Tourism project
(R01DA049644, PI: Strathdee), called La Frontera. The overall goal of the parent grant is to
characterize trends in incidence of HIV, HCV, and overdose associated with binational drug markets
and drug tourism between San Diego and Tijuana, Mexico. La Frontera conducts prospective
quantitative and qualitative surveillance of retail drug markets in both San Diego and Tijuana, coupled
with epidemiologic data collection of 600 PWID (200 drug tourists from San Diego; 200 non-drug
tourists from San Diego and 200 non-drug tourists from Tijuana). This Diversity Supplement is
focused on access to water sanitation and hygiene (WASH) among the population of people
who inject drugs (PWID) studied in La Frontera, and is planned to be feasibly conducted in the
proposed two-year funding period. Data analyses proposed in this supplement will include data from
La Frontera conducted among PWID in the Tijuana and San Diego metropolitan area, which was
already collected. This dataset included a six-, 12-, and 18-month follow up during the COVID-19
pandemic, representing a valuable opportunity to assess shifts in health behavior and health risks
among PWID in both cities. AIM 1 will describe WASH access at baseline interview, and at 6-month
follow-up, among men and women who inject drugs in the Tijuana and San Diego metropolitan area,
and by housing status during the COVID-19 pandemic period, from October 2020 to December 2021.
AIM 2 will determine if limited access to WASH is associated with higher incidence and prevalence of
abscesses in injection locations at over an 18-month follow-up period among PWID in the TJ and SD
metropolitan area. AIM 3 will examine if limited access to WASH is associated with higher
seroprevalence of SARS-CoV-2 infection among PWID in the Tijuana and San Diego metropolitan
area. WASH is a human right and is often violated among vulnerable communities such as PWID, and
people experiencing housing insecurity. Although access to WASH services has been poorly studied
among PWID, there is ample room for concern, as non-hygienic environments or practices could
increase risk of developing abscesses, HIV or Hepatitis C complications, and myocarditis. This
supplement offers Dr. Calderon Villarreal a unique opportunity to collaborate and mutually strength the
understanding of PWID’s unmet needs and how they are driving poor health outcomes and will support
her goal to becoming an independent investigator focusing on the intersection between substance use,
WASH and health disparities.

Public health relevance
This Diversity Supplement will provide the first comprehensive evaluation of the access to, and sources of, water, sanitation, and hygiene (WASH) among people who inject drugs (PWID) in the Tijuana and San Diego metropolitan area. The project has a special focus on how WASH mediates injection-related health risks for PWID. Analyses will be conducted with a focus on evaluating inequalities between distinct sociodemographic groups of PWID, as well as between individuals living on both sides of the US-Mexico border, and the incidence/prevalence of abscess, based on secondary data collected in the parent grant, La Frontera. The work will also assess the association between WASH access and SARS-CoV-2 seroprevalence, as well as shifts in WASH access occurring during the COVID-19 pandemic.